Gut bacterial metabolism of the side-chain of corticosteroids

Project Summary
The metabolism of corticosteroids by host-associated microbiomes rivals that of host peripheral tissues. Side-
chain metabolism of corticosteroids is capable of changing the functional class of steroid. The focus of the current
project is elucidating the microbial enzymes involved in (Aim 1) the side-chain cleavage of cortisol and reduction
of 17-keto resulting in 11-oxy-androgens (Aim 2) 21-dehydroxylation yielding 11-oxy-progesterone derivatives.
These pathways are significant because they are hypothesized to potentiate diseases relevant to the mission of
NIH. The formation of 11-oxy-androgens in the intestine and urinary tract is hypothesized to affect host immune
function, and may be a risk factor for prostate cancer. The formation of 11-oxy-progesterone derivatives has
been shown to be pro-hypertensive through a well-established mechanism involving the ‘dehydrogenase
hypothesis’. Our preliminary data demonstrates that we have established the side-chain cleavage enzyme,
steroid-17,20-desmolase, from both gut and urinary tract bacteria. The end-product 17-keto steroid can then be
reduced to either testosterone or epitestosterone derivatives. We have cultured anaerobes that encode the
enzymes for (epi)testosterone formation, and our preliminary data demonstrates our expertise and the feasibility
of locating and characterizing these enzymes. We also show a cultured anaerobe capable of corticosteroid 21-
dehydroxylation and formulated a hypothesis and preliminary data that a putative corticosteroid dehydroxylation
(csd) gene cluster encodes 21-dehydroxylation. Once located, we will apply previously established bioinformatics
approaches to uncover the diversity of host-associated bacteria encoding homologous sterolbiome enzymes
(phylogenetic analysis, sequence similarity networks). However, to address evolutionarily analogous sterolbiome
enzymes with the same functions described above, we will utilize an unbiased functional metagenomic approach.
We present additional robust preliminary data demonstrating the feasibility of our studies that include (1)
collection of 180 stool samples for functional metagenomic screening (2) utilization of RNA-Seq for steroid-
inducible gene discovery (3) heterologous expression and characterization of numerous microbial sterolbiome
enzymes (3) establishment of enzyme assays and steroid metabolomics. The research proposed in this
application is innovative, in our opinion, because it represents a new and substantive departure from the status
quo established four decades ago by combining transcriptomics, heterologous protein expression, enzyme
assays, phylogenetic and sequence similarity networks, synthetic biology, and functional metagenomic
screening to discover the precise nucleic acid sequences encoding corticosteroid side-chain metabolizing
enzymes. Successful completion will potentiate research into the cause and effect relationships between the gut
sterolbiome and host diseases, and is expected to lead to translational approaches (probiotics, enzyme
inhibitors) to modulate the gut microbiome to restore and maintain health.

Public health relevance
Project Narrative Host associated microbes are capable of corticosteroid biotransformations that affect human physiology and potentiate numerous diseases. In order for the biomedical community to target and modulate bacterial steroid metabolism, the enzymes responsible must be identified and characterized. This proposal describes our approach to elucidate the nucleic acid sequences encoding enzymes involved in corticosteroid metabolism, characterizes these enzymes, and determine diversity of these enzymes and pathways in the human microbiome.